Community Engagement and Dissemination Core

PROJECT SUMMARY/ABSTRACT--CEDC
The mission of the Community Engagement and Dissemination Core (CEDC) of the MADRES Environmental
Health Disparities Center is to increase public understanding and awareness of the effects of the environment
on women’s health, especially during pregnancy and the postpartum period, by engaging Center researchers,
scientists and clinicians with residents, communities, health care providers, policymakers and public health
officials to create equitable and sustainable partnerships. The CEDC engages with community-based social
justice and health care organizations working in health disparity communities, scientists and public officials using
a multi-directional and culturally-appropriate and language justice framework to disseminate information,
research findings, and policy strategies to understand and reduce maternal environmental health disparities. The
CEDC has developed a successful model to engage Latinas together with multi-ethnic health disparity
communities in addressing household- and neighborhood- level environmental health concerns in urban Los
Angeles, CA. In the current award, we developed novel methods to train mothers, residents and youth in
participatory environmental health workshops, conducted community air monitoring, collaborated with multiple
stakeholders implementing a novel effort to assess and reduce toxic air emissions at a neighborhood scale, and
leveraged traditional and nontraditional communications techniques to disseminate Center science broadly. In
the MADRES renewal we will continue to advance environmental health literacy among mothers and leverage
new partnership with community health workers. We will disseminate research to local and national audience
utilizing innovative communication methods and develop culturally-appropriate tools to share findings and results
with MADRES cohort participants. The CEDC will further provide strategies to eliminate, reduce or mitigate
adverse environmental health impacts to vulnerable populations and evaluate the success of our CEDC
activities.